Planning and Evaluation Core

Planning and Evaluation Core
The Planning and Evaluation Core is composed of the Partnership's Internal Advisory Committee, Program
Steering Committee, Executive Committee and external evaluators to provide oversight of the overall
Partnership activities and programs. It will be responsible for all aspects of planning, monitoring, evaluation
and tracking of Partnership activities. In addition, this core serves as a platform from which the Partnership's
PIs can discuss strategic plans that can move the U54 Partnership towards new initiatives that strengthen the
goals and mission of both institutions. The specific goals and objectives are: 1) The Partnership PIs (Drs.
Ahles, Gany, Hubbard and Barabino) will collaborate with the Internal Advisory Committee and the Program
Steering Committee to ensure ongoing planning, monitoring, evaluation and tracking of Partnership activities
including: a. Coordination and management of the solicitation of new research proposals; b. Review and
selection of full and pilot projects for funding, monitoring of project progress, and decision making regarding
discontinuation of funding for projects not meeting goals; c. Development of new initiatives based on
opportunities presented on a national level (e.g., Blue Ribbon priorities, RFAs and PARs issued) or at either
institution; and d. Identification of faculty searches that are potentially synergistic with Partnership goals. 2)
The Partnership PIs will monitor and evaluate all aspects of Partnership functioning, in collaboration with the
external evaluator Dr. Bosch: a. track pertinent data that monitors and assesses the Partnership's goals and
objectives, such as publications and grant submissions by investigators, student tracking data, and community
outreach assessments; b. monitor and evaluate all aspects of the proposed educational programs; c. utilize
the RE-AIM framework to monitor and evaluate all aspects of the proposed outreach(PCORE) activities; and d.
ensure that the Linguistic and Cultural Responsiveness Shared Resource Core meets target metrics.